UCLA Clinical Translational Science Institute

SUMMARY/ABSTRACT
The UCLA Clinical and Translational Science Institute is a research partnership of the University of California
Los Angeles, Cedars-Sinai Medical Center, Charles R. Drew University of Medicine and Science and the
Harbor-UCLA Medical Center/ Lundquist Institute for Biomedical Innovation. Our mission is to bring biomedical
innovations to bear on the greatest health needs of Los Angeles, an ethnically and economically diverse
metropolis of more than 10 million people. In the past 10 years, we have built a robust research infrastructure
to support our mission. In partnership with the community, we have made important advances against the
leading causes of preventable disability and death. Supporting these advances is a streamlined regulatory
infrastructure. We have instituted scientific review, reduced time-to-study-activation by 42%, and achieved
100% compliance with ClinicalTrials.Gov. As we enter our next decade, we are building on our progress by
augmenting the integration with our institutional hub partners and broadening collaborations in the community
as well as with investigators outside the health professions. Because Equity, Diversity and Inclusion (EDI) is a
foundational principle of our CTSI, we have embarked on an Inclusive Science Initiative, led by our EDI Senior
Associate Director, to ensure that our research and training programs continue to embrace this guiding
principle. Through new T1-T4 seminars and team science trainings and opportunities, we are equipping our
trainees to conduct multidisciplinary team science across the translational spectrum. We are systematically
evaluating our CTSI outcomes and overall impact. The UCLA CTSI has five specific aims: 1) Enhance
education and training to prepare and expand the translational workforce, 2) Engage stakeholder
communities in multidisciplinary team science and disseminate successful models of collaboration, 3)
Integrate special populations, including those experiencing health disparities, into translational
research, 4) Improve methods and processes to accelerate efficient, high-quality, multisite research,
and 5) Provide informatics solutions to advance high-impact translational science.

Public health relevance
PROJECT NARRATIVE With 10 million residents, Los Angeles County is the most populous in the US; three-quarters of residents identify as ethnic minorities and more than one-third were born outside the US; and nearly 1.5 million people are below the poverty line. Rates of premature death and disability related to heart disease, diabetes, stroke and violence exceed national averages; the disease burden is magnified by language barriers, cultural beliefs, poverty and disparities in access to care. The goal of the CTSI is to bring biomedical innovations to bear on the greatest health needs of Los Angeles—one of the nation's most ethnically, socially and economically diverse counties.